The short and long-term dynamics of opioid/stimulant use: Mixed methods to informoverdose prevention and treatment related to polysubstance use

Project summary
In response to NOT-DA-23-011, this administrative supplement will expand the scope of the parent project
(R01DA057673, MPI: Genberg and German) on short and long-term effects of polysubstance use to
incorporate collection of quantitative and qualitative data on criminal legal involvement. Specifically, this
application will broaden and complement the skills of our investigative team to include researchers with
expertise on characterizing the intersection of substance use and criminal legal involvement, with a focus on
people who use drugs’ interaction with street-level police officers. The overall objective of this administrative
supplement is to elucidate the relationship between polysubstance use and encounters with police and other
elements of the criminal legal system in a community-recruited cohort of people who use drugs in Baltimore,
MD. To date, most studies have only examined the association between polysubstance use and incarceration
cross-sectionally, yet rigorous longitudinal data on the upstream drivers of incarceration, such as interactions
with police, are lacking. Overcoming this knowledge gap is important as pre-arrest diversion is seen as a
critical opportunity for police to link people who use drugs to community-based recovery services yet our
understanding on police-PWUD interactions is limited with respect to polysubstance use. Thus, we intend to
collect detailed quantitative and qualitative data on anticipated and realized experiences with street-level police
(e.g. stopped, arrested, harassed) among PWUD by accomplishing the following specific aims to: 1) evaluate
real-time associations between polysubstance use and the mediating role of social determinants (e.g. housing
instability and employment status) on negative police encounters; and 2) characterize experiences,
perceptions, and consequences of criminal legal involvement during polysubstance using episodes. We will
accomplish Aim 1 by adding criminal legal involvement measures to ongoing data collection of ecological
momentary assessments among 200 PWUD. To complement the quantitative results, we will conduct 20 in-
depth interviews with PWUD who had recent encounters with street-level police to contextualize the findings in
Aim 1. We will leverage findings from this supplement to inform an R34 preliminary effectiveness trial to pilot
pre-arrest deflection to recovery support, MOUD, and wrap-around services for people with severe substance
use disorder, including individuals who engage in polysubstance use.

Public health relevance
Project narrative Many people who engage in polysubstance use have frequent interactions with the criminal legal system, especially with street-level police. We will leverage ongoing real-time and qualitative data collection from the parent study (R01DA057673, MPI: Genberg and German) to elucidate how polysubstance use and criminal legal involvement mutually reinforce each other. The long-term goal of this supplement is to identify intervention targets to disrupt this cycle and develop pathways to recovery and treatment services.